ENACT: Translating Health Informatics Tools to Research and Clinical Decision Making

Several challenges exist in the conduct of EHR-based translational research. First, CTSA hubs vary
substantially in their capacity to address challenges in EHR data collection, data quality, data harmonization,
methodology for deep phenotyping, maintaining patient privacy, variability in ontology, and limited ability to
transfer data beyond institutional firewalls. Second, there is an unmet need for readily available, easily
accessed informatics tools that facilitate EHR-based research and can be rapidly disseminated and
implemented across all CTSA hubs. Third, CTSA hubs seek guidance on the complicated data use
agreements (DUAs) and governance needed to enable data sharing and analysis of shared data. With funding
from NCATS, we created a federated system, the ACT Network, that crafted a broad DUA and stood-up local
clinical data warehouses (CDWs) at 57 CTSA hubs, created an information superhighway to query the CDWs
that include >142M patients, and democratized data access for cohort discovery to all CTSA hub investigators.
We initially developed ACT to support the planning and design of multisite clinical trials, which it did well and
additionally highlighted the potential value of EHR data for deeper analysis. While the ACT Network has limited
analytic capacity in its present form, we will now address this opportunity to fully leverage the research
potential of EHR data from almost half the US population through Evolve to Next-Gen ACT (ENACT). We will
create a user-friendly collaborative research and computing environment with cutting edge analytical methods.
We will start with tools and a dashboard to monitor data quality, provide guidance to individual sites to improve
data quality, and provide contextual reports that help investigators interpret their data. We will also apply
natural language processing to extract clinical concept data from reports and notes in the EHR, provide user-
friendly interfaces that are interoperable with common data models (i2b2, OMOP, PCORnet), expand
ontologies (lifestyle factors, genetic variants, retired codes), and provide other sophisticated informatics tools,
including those developed by our team and by others. In parallel, we will create a platform and provide
statistical and machine learning capacity that clinical and translational scientists can apply to EHR data, either
through federated analyses or, for more complex compute-intensive analyses, in a temporary enclave. We
envision leveraging these informatics tools and EHR data to enable clinicians to generate evidence that can be
applied to improve patient care. With every step, we will design for dissemination and sustainability to foster a
learning informatics system. We will prioritize unmet needs among stakeholders, solicit input on the desired
features, and ensure that ENACT satisfies the needs of targeted end users. We will leverage the I-Corps@
NCATS program for customer discovery, beta testing, and business model development for sustainability. We
will collect data through pilot trials of each tool and resource that will be used to create marketing materials and
to develop sustainability models that include cost-recovery based on real-world time and effort required.

Public health relevance
“Evolve to Next-Gen ACT” (ENACT) will develop and distribute new software tools that allow scientists and clinicians from 57 CTSA institutions to search for and analyze de-identified data from the electronic health records of over 142 million Americans across the country. Our user- friendly ENACT interface can be used on standard laptops to access many types of data from many sources to advance new medical discoveries for everyone and help with clinical care planning for individual patients.